Chronic Alcohol, Dementia, and CNS Fluid Homeostasis

Project Summary/Abstract
Alcohol use disorder (AUD) in mid-life is a significant, independent predictor of late-life dementia, particularly
vascular cognitive impairment and dementia (VCID) that includes the common subtype cerebral amyloid
angiopathy (CAA) characterized by deposits of amyloid-β (Aβ) in the cerebral vasculature. In only one decade,
from 2005-2014, the rate of alcohol binging among the elderly rose 20% overall and by 50% in women only. The
mechanisms underlying alcohol’s toxic effects on the central nervous system (CNS) remain incompletely
understood, which limits the development of strategies targeted to reduce or prevent disease burden in heavy
drinkers with and without CAA VCID. An underlying cause of alcohol’s damaging effects on the CNS is a poorly
understood dysregulation of CNS fluid homeostasis. Preliminary evidence indicates that alcohol-associated
abnormal fluid homeostasis manifests as enlarged cerebral ventricles and altered CSF flow dynamics. In
humans, specifically, this manifests as lateral ventricular enlargement, and may reflect not only tissue loss but
also itself be contributing to tissue damage and cognitive impairment. We propose that ethanol disrupts
fundamentals of fluid homeostasis, by reducing CSF flow through the interconnected glymphatic and lymphatic
systems, through biochemical and neuroimmune alterations thereby directly damaging the tissue. The
functioning of glymphatic/lymphatic system supports fluid homeostasis and clears waste and toxins from the
brain. Our proposed studies include a comprehensive series of experiments to quantitatively analyze alcohol’s
effects on CSF secretion, glymphatic and lymphatic transport, and CSF/lymph ‘omics’ profiling in normal brain
and with CAA VCID pathology. In Aim 1, we will determine how cEtoh interferes with CSF secretion in rats
with/without VCID, using a novel MRI acquisition method to measure choroidal CSF secretion, as well as blood
perfusion of the choroid plexus and cortex. We will also implement MRI sequences to measure brain
morphometry in cEtoh-exposed rats with/without VCID and sample CSF, the meninges, and brain tissue to study
pathology and biochemical lymphatic and inflammatory factors. In Aim 2, we will assess how cEtoh affects
glymphatic-lymphatic transport, cerebral and meningeal lymphatic pathology, lymphatic waste output and
cognition in rats with/without VCID. We will use dynamic contrast-enhanced MRI and computational fluid
dynamics to measure CSF flow dynamics, glymphatic transport, and lymphatic waste drainage as affected by
cEtoh and VCID, as well on CAA pathology and cognitive decline. In Aim 3 we will study how cEtoh compromises
biochemical signaling and bio-physical changes in the CSF and lymph, including proteins that regulate fluid
volume (renin-angiotensin) and proteins functioning in ion transport/signaling (Voltage dependent calcium signal,
V-type proton ATPase and Carbonic Anhydrase). Molecular pathways that we identify can later be probed for
therapeutic benefit.

Public health relevance
Narrative From 2005-2014, the rate of alcohol binging among the elderly rose 20% overall and by 50% in women only, and Alcohol use disorder (AUD) in mid-life is shown to be a significant, independent predictor of late-life dementia, particularly vascular cognitive impairment and dementia (VCID) including the Cerebral Amyloid Angiography (CAA) subtype. CAA VCID is accompanied by disruptions in the toxin-clearing flow of fluid in the brain, and there is reason to believe that alcohol abuse can compromise the fluid flow through the brain and worsen the CAA and dementia, particularly later in life. Therefore our goal is to learn how and why (i.e., biochemical regulators) the fluid flow is disrupted and if it can be improved as a potential way to help people with VCID, especially those who engage in risky levels of drinking.